Sensory Mechanisms and Disorders

DESCRIPTION (provided by applicant): This training program for predoctoral students and postdoctoral fellows provides an interdisciplinary education and research experience in hearing, balance and chemical senses (HBCS). Predoctoral training is based in one of the 16 academic departments and degree-granting graduate programs with which the 23 training faculty are associated. Doctoral thesis research and postdoctoral research training reside primarily within the laboratories of the mentors. Our affiliated faculty provides outstanding training in each of their corresponding disciplines: bioengineering, cellular and molecular biology, genetics, molecular and neurophysiology, developmental biology, and biopsychology of sensory processing. The HBCS program integrates investigators in auditory, vestibular, and chemosensory research with trainees from across these disciplines and thereby fosters innovative training opportunities into mechanisms and disorders of hearing, balance, taste and smell. Cross- disciplinary integration is made possible by the training program through: a) introductory and advanced courses in sensory systems; b) seminars relevant to hearing, balance and chemical senses from experts within and outside the University of Michigan; c) student and faculty seminars, journal clubs and research forums; d) exposure to clinical research issues in Otolaryngology and clinical/translational resources available at the University of Michigan Medical School, and e) training in research standards and ethics. Support for 4 predoctoral and 3 postdoctoral trainees is requested. Predoctoral trainees will be selected from the most highly qualified graduate students in the training faculty's affiliated departments and programs. Interest and motivation for research in sensory systems will be an important selection criterion. Postdoctoral trainees (Ph.D., M.D., or D.D.S.) will be selected from applicants with a strong commitment to sensory biology and promising research backgrounds.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our primary goal for this training program is to attract promising scientists to the research fields of hearing, balance, taste and smell and to provide them with the mentoring and training that will result in their pursuit of important new knowledge through productive research careers in these areas. A better understanding of these sensory systems will provide important insight into many human disorders that greatly affect quality of life and will lead to new therapeutic treatments.